Using an innovative quality improvement process to increase delivery of evidenced-based CVD risk factor care in community mental health organizations

Project Summary NA

Public health relevance
Narrative NA